DNA Protein Cross-Links: Metabolic Sources and Repair

PROJECT SUMMARY
DNA-protein cross-links (DPCs) form when cellular proteins become irreversibly trapped to DNA as a result
of cellular processes such as histone demethylation, lipid peroxidation, and elevation of reactive oxygen
species. External and therapeutic agents such as UV light, transition metals, and anti-tumor drugs also induce
DPC formation. These bulky lesions interfere with essential DNA-protein interactions necessary for DNA
replication, recombination, transcription, and repair. DPC repair appears to be essential for normal cell function,
as mice deficient in the DPC protease enzyme, SPRTN, are embryonically lethal. Mutations in SPRTN cause
Ruijs-Aalfs syndrome in humans, which is characterized by elevated levels of DPCs, genome instability,
accelerated aging, and high risk for cancer. Despite the ubiquitous formation of DPCs and their implication in
human disease, the structural identities and repair pathways for this class of adducts are not well-known. DPCs
are chemically heterogeneous and the study of such bulky biomolecular conjugates is challenging. There is a
critical need to generate new tools and strategies to precisely define how endogenous electrophiles elevated
in metabolic diseases contribute to the formation of DPCs and, ultimately, contribute towards initiation and
progression of metabolic disorders. The long-term goal of the research in my laboratory is to identify DPCs
and repair pathways that may ultimately be used for early detection and risk assessment of metabolic diseases.
Over the next five years, this project will test the central hypothesis that the specific molecular signatures of
DPCs can be profiled across metabolic states using the multistage fragmentation capability of the mass
spectrometer (MS). When combined with specific chemical characterization, this approach will reveal specific
DNA-protein interactions relevant to DNA repair. Collectively, these studies will 1) identify metabolites
responsible for DPCs during altered cellular metabolism and establish analytical tools to 2) uncover the proteins
contributing to DPC formation and 3) identify enzymes participating in DPC repair. This approach is innovative
because this study will, for the first time, characterize molecular mechanisms for DPC formation and repair
using mass spectrometry-based adductomics technology. This technology is analogous to other -omics
methodologies such as metabolomics, proteomics, transcriptomics and genomics which make the study of
complex human diseases from a global perspective possible. Expected outcomes: our studies will provide
insight into metabolites capable of forming DPCs and provide insight into cellular pathways that contribute to
genome instability. An increased understanding of such metabolites lays the foundation for preventative
strategies that help limit genomic instability and improve human health.

Public health relevance
PROJECT NARRATIVE DNA-protein cross-links (DPCs) form when cellular proteins become irreversibly trapped to DNA as a result of endogenous cellular processes such as histone demethylation, lipid peroxidation, and formation of reactive oxygen species. If not repaired, the resulting DNA lesions can have toxic results or lead to heart disease and aging. The goal of this project is to understand how human cells cope with DPCs by innovative mass spectrometric strategies.